MOLECULAR AND GENETIC CHARACTERIZATION OF EMS-INDUCED LETHAL MUTATIONS IN DROSOPHILA ENRICHED FOR ORTHOLOGS OF HUMAN DISEASE-CAUSING GENES

PROJECT SUMMARY/ABSRACT
Forward genetic screens through chemical mutagenesis in Drosophila have made significant contributions to
fundamental discoveries that span multiple biological disciplines and provided novel biological insights that are
directly relevant to diverse human diseases. However, due to the difficulty to map causative mutations and its
labor-intensiveness, many researchers cannot take advantage of this approach. A collection of fly strains that
are obtained from a well-designed chemical mutagenesis screen that simultaneously explores numerous
phenotypes can serve as excellent resource for the broader research community since a number of secondary
screens could be conducted on the same collection and individual mutant lines can be used to probe diverse
biological processes that are evolutionarily conserved. However, such resource does not exist in the Drosophila
community and most fly strains isolated from previously conducted chemical mutagenesis screens were left
unmapped and subsequently discarded. We performed a large scale F3 clonal EMS-mutagenesis screen on the
Drosophila X-chromosome and have been maintaining 1,385 recessive lethal mutant strains. So far, we have
molecularly mapped the lethality-causing mutations of 614 lines to 165 genes. This collection was built on a
healthy isogenic y w FRT19A X-chromosome using low concentration of EMS and have been selected for
mutants that show interesting morphological and/or neurophysiological phenotypes in mosaic animals.
Importantly, the careful design of the screen allowed us to enrich for essential genes that are evolutionarily
conserved (~90% of mapped genes are conserved in human) and have direct relevance to human diseases
(~70% of mapped genes have human homologs that cause genetic diseases in human). Mapped mutations from
this collection have been used in >80 manuscripts by many laboratories that study a variety of biological contexts
and have also led to discovery of novel human disease genes and mechanisms. Here, we will sequence and
attempt to demonstrate the causality of the remaining 771 unmapped lines that have been maintained using a
new streamlined sequencing and bioinformatic analysis pipeline followed by rigorous genetic analysis. Upon
completion, this project will provide Drosophila researchers with a collection of >1,000 fly strains which are
carefully phenotyped that have been generated on a well-defined genetic background and mapped to >300
conserved genes. This resource can be used to perform numerous secondary screens and subsequent deep
investigations by numerous laboratories in the US and around the world. Missense mutations identified from this
effort can further provide novel structure-function information on conserved proteins. The rich phenotypic
information of clonal phenotypes will allow us to establish a comprehensive database that could be mined by
Drosophila biologists as well as experts in other disciplines such as clinical geneticists interested in novel disease
gene discovery in humans.

Public health relevance
PROJECT NARRATIVE Forward genetic screens in the fruit fly, Drosophila melanogaster, have made significant contributions to fundamental discoveries that span multiple biological disciplines. We have generated a large collection of extensively-phenotyped chemically induced lethal mutations on the Drosophila X-chromosome, and demonstrated the utility of this collection to study a variety of human genetic disorders. In this proposal, we will apply the latest molecular sequencing and genetic mapping technology to identify the causative mutations of >700 mutant strains to create a comprehensive knowledgebase and resource of Drosophila strains that can be used to predict and mechanistically study novel disease-causing genes in human.